Cardiac Lymphatics in Development and Repair

Abstract
With cardiovascular disease the leading cause of death worldwide, valvular heart disease
(VHD) currently affects 2.5% of the US population and is one of the most important factors
responsible for cardiovascular disease events. Even more surprising, a large-scale clinical study
found previously undiagnosed VHD in 50% of the elderly population, further accentuating the
need for a better understanding of the pathophysiology of VHDs. However, VHDs remain
understudied, and the underlying pathological mechanisms are poorly characterized.
Adrenomedullin (AM), a peptide hormone with numerous cardiovascular roles, has been recently
shown as the most potent prognostic biomarker in aortic stenosis. Moreover, the AM decoy
receptor, Atypical Chemokine Receptor 3 (ACKR3) also attenuates pro-fibrotic signaling and
ACKR3-deficient mice display severe valvular defects, including thickened semilunar valves due
to increased proliferation of the semilunar valve mesenchymal cells, and develop ventricular
fibrosis. Nevertheless, the role of AM and its decoy receptor in cardiac valve development or
function has yet not been investigated in detail. With this knowledge in mind, we hypothesize that
endothelial and endocardial AM - ACKR3 signaling is a key player in regulating cardiac
valvulogenesis and aberrant cardiac fibrosis. Using state-of-the-art light-sheet microscopy, single-
cell RNA transcriptomic and animal model approaches, we propose to build on our current
expertise GPCR signaling to broad our knowledge on how AM - ACKR3 signaling modulates
cardiac health. Our studies will expand our understanding of the underlying molecular
mechanisms leading to valvular defects and cardiac fibrosis formation and uncover possible
molecular targets for patients with valvular heart diseases.

Public health relevance
Project Narrative Proper development and function of cardiac valves is essential for survival and defects in cardiac valves can lead to heart failure or sudden death. Despite the importance of cardiac valves, we lag in our knowledge of factors and cell types that coordinate their normal development and function. Studies proposed in this administrative supplement aim to address these questions by using sophisticated imaging and genetic mouse model systems to fulfill several of the stated goals of the NHLBI Cardiovascular Advances in Research and Opportunities Legacy (CAROL) Act (NOT-HL-23-078).